TR&D Project 3

PROJECT SUMMARY/ABSTRACT
The overarching objective of TR&D 3 is to design and develop a novel category of immunomodulatory proteins,
both as tools to study the immune response and as targeted disease therapeutics. Cytokines control all aspects
of immune homeostasis and are thus of great interest as potential interventions to either stimulate immune
activity for treatment of cancer and infectious diseases or to suppress activity response for treatment of
autoimmune disorders and to promote transplant tolerance. Unfortunately, natural cytokines have several
intrinsic properties that limit their therapeutic application, including: (1) Pleiotropy, which hinders specificity,
safety, and efficacy; (2) Instability, which leads to challenges in formulation and manufacturability; and (3) Short
in vivo half-life, which limits durability of disease control.
To overcome inherent limitations of natural cytokines, emerging molecular engineering technologies aim to
modify native cytokines in order to improve their suitability as drugs. Our team has established a unique approach
to empower cytokines as therapeutics: fusion of natural cytokines to anti-cytokine antibodies, creating
intramolecularly assembled immunocytokines (ICs) that selectively direct the activities of cytokines to particular
immune cell subsets while also extending circulation half-life. Using this approach, we generated a
complementary pair of interleukin-2 (IL-2)-based ICs that mount either immune effector cell-biased
(immunostimulatory) or regulatory T cell (Treg)-biased (immunosuppressive) responses. Our promising
preliminary work in developing ICs illustrates the potential for designing off-the-shelf molecular therapeutics that
selectively manipulate immune activity. Here, we aim to advance clinical translation of our technology by
evaluating IL-2 ICs in animal models of cancer, inflammatory bowel disease, and type 1 diabetes. In parallel, we
will extend our versatile cytokine/antibody fusion protein concept to the IL-7 system to promote T cell survival.
We will also harness our team’s recent discovery of a particularly suppressive subset of tumor-infiltrating Tregs to
specifically target an antagonistic IC to the tumor microenvironment that will promote anti-cancer immunity. Our
interdisciplinary team of protein engineers and immunologists is uniquely equipped to carry out the proposal
aims, which promise to help realize the potential of cytokine therapeutics. The IC deliverables resulting from this
project will be integrated with other platforms in the Center, installing these targeted proteins on artificial antigen-
presenting cells from TR&D 1 to promote antigen-specific immune activation, and coating ICs on
nanoimmunomaterials in TR&D 2 to selectively direct gene delivery. Moreover, ICs will be iteratively developed
through Collaborative Projects 1, 8, 9, and 10 and deployed in Service Projects 8, 10, and 12. Collectively, the
proposed work will demonstrate the translatability, modularity, and antagonistic potential of ICs, presenting a
novel molecular engineered technology for biasing immune activity to achieve therapeutically relevant outcomes.